Papillary thyroid cancer and tumor-associated macrophages

DESCRIPTION (provided by applicant): The objective of this proposal is to use this 5-year training grant to acquire the knowledge and skills necessary to become an independent researcher. The PI will be mentored by Dr. James Fagin who is a leading scientist in thyroid cancer biology at Memorial-Sloan Kettering Cancer Center. The purpose of this research is to explore the role of tumor-associated macrophages (TAMs) in thyroid cancer progression. Multiple lines of evidence demonstrate that tumors paradoxically alter the host anti-tumor immune response to promote tumor progression through immune-mediated tumor growth, angiogenesis, lymphangiogenesis, invasion and metastases. We have shown that in human thyroid cancers, TAMs correlate with tumor grade. In advanced stages of thyroid cancer, TAMs correlate with invasion and decreased survival. This suggests that TAMs facilitate thyroid cancer progression. Our lab has several mouse models of Braf- induced thyroid cancers, which is the most common oncogenic event in human thyroid cancers. Thyroid cancers in this model, similar to humans, are infiltrated with TAMs, and tumors progress to invasion, poorly- differentiated cancers and metastases. Our hypothesis is that TAMs facilitate thyroid cancer progression. We will test this hypothesis using several genetic approach to deplete TAMs in thyroid cancer mouse models. In preliminary data, we show that the depletion of TAMs in thyroid cancers impairs thyroid cancer initiation and progression. This may be in part through TAM-dependent tumor stromal expansion with cancer-associated fibroblasts (CAFs) and pericytes, as we will show in preliminary data. Our specific aims are to characterize the kinetics and differentiation status of TAMs in thyroid cancers and determine which chemokines are required for TAM recruitment and/or differentiation. We will examine the effects of TAMs on the recruitment, differentiation and/or proliferation of CAF progenitors from the bone-marrow and thyroid. Finally examine the effects of TAMs directly on thyroid cancer derived CAFs and pericytes. The results of these investigations will help identify potential mechanisms of thyroid cancer pathogenesis through recruitment and interactions of host immune cells. This knowledge and understanding can then be used to develop new targets for cancer therapy for patients whose disease has not responded to traditional treatments.

Public health relevance
PUBLIC HEALTH RELEVANCE: The results of these investigations will help identify potential mechanisms of thyroid cancer pathogenesis through recruitment and interactions of host immune cells. This knowledge and understanding can then be used to develop new targets for cancer therapy for patients whose disease has not responded to traditional treatments. Project Narrative The results of these investigations will help identify potential mechanisms of thyroid cancer pathogenesis through recruitment and interactions of host immune cells. This knowledge and understanding can then be used to develop new targets for cancer therapy for patients whose disease has not responded to traditional treatments. __SpecificAimsTextDelimiter__ a. Statement of Hypothesis and Specific Aims: Tumors are richly infiltrated with tumor-associated macrophages (TAMs) and multiple lines of evidence indicate that the tumor microenvironment paradoxically alters host immune cells into tumor-promoters. The presence of TAMs in human breast, prostate and cervical cancers is associated with tumor progression and poor prognosis(reviewed in 3). In mouse cancer models, TAMs are causally involved in cancer progression4, 5. Infiltration of TAMs in thyroid cancers has been observed6, yet their role in progression has not been well investigated. We found a marked increase in the density of TAMs in poorly-differentiated and anaplastic thyroid cancers as compared to well-differentiated thyroid cancers1. Moreover, in patients with advanced thyroid cancers, increased TAMs correlate with extrathyroidal invasion and decreased survival1. We recently identified oncogenic BRAFV600E as the most common mutation in radioactive iodine refractory, advanced human thyroid cancers and in tumor metastases2. This strengthens the rationale to investigate the cooperativity between oncogenic BRAFV600E and tumor-promoting TAMs in the pathogenesis of thyroid cancer in mouse models. We will present new evidence that selective targeting of TAMs using three distinct genetic strategies in Braf- induced papillary thyroid cancers (PTCs) severely impaired PTC initiation, reversed aspects of the classical papillary phenotype and strikingly reduced the stromal compartment of myofibroblasts (consisting of cancer- associated fibroblasts [CAFs]) and pericytes). Our hypothesis is that distinct populations of TAMs, recruited through tumor-derived colony stimulating factor-1 (CSF-1) and macrophage chemoattractant protein-1 (MCP-1), facilitate PTC initiation and progression by a) stimulating tumor angiogenesis and lymphangiogenesis, b) facilitating the disruption of thyroid follicular structures and promoting the dedifferentiation of follicular cells and c) by enhancing the invasive potential of cancer cells. TAMs may alter these tumor hallmarks directly through TAM-derived growth factors, proteases or chemokines and/or indirectly through the recruitment and/or proliferation of CAFs and pericytes. 1. Specific Aim 1: a) Characterize the kinetics of TAM infiltration and their differentiation status during PTC initiation; b) Determine whether chemoattractants CSF-1 and/or MCP-1 facilitate the recruitment, proliferation and/or activation of TAMs and c) Examine whether TAMs contribute to tumor angiogenesis, lymphangiogenesis, invasion and de-differentiation of PTCs. We will determine the kinetics and differentiation status of TAMs infiltrating PTC acutely after dox-inducible oncogenic Braf expression in thyroid cells of transgenic mice. Next, we will genetically target CSF-1 and MCP-1 in PTCs followed by adoptive transfer of undifferentiated monocytes to determine if tumor-derived CSF-1 and/or MCP-1 are required for TAM infiltration and tumorigenesis. Finally, we will examine how TAM depletion impacts the tumor angiogenesis, lymphatic vessel density, invasive potential and progression to poorly- differentiated thyroid cancers. 2. Specific Aim 2: Examine the role of TAMs in the expansion of stromal cancer-associated myofibroblasts and pericytes during PTC initiation. Our preliminary data indicate that TAMs are required for the expansion PTC stromal αSMA+ CAF and pericytes. Our hypothesis is that TAMs enrich this stromal compartment by a) promoting the recruitment and/or differentiation of BM-derived mesenchymal stem cells (MSCs) into CAFs, b) stimulating the differentiation and proliferation of thyroid- derived fibroblasts into CAFs and/or c) directly stimulating the proliferation of CAFs/pericytes in the tumor microenvironment. We will explore these hypotheses by injecting BM-derived GFP- expressing MSCs into dox-induced PTC mice to determine if they home to Braf-induced thyroid tumors and if this requires the presence of TAMs. In vitro, we will examine whether TAMs induce the differentiation of BM-derived MSC and/or thyroid-derived naïve fibroblasts into CAFs/pericytes. Finally, we will determine if TAMs support the proliferation of CAFs/pericytes in co-culture experiments.